Piloting developmental PFAS exposure to identify gene-environment interactions in autism risk

The incidence of Autism Spectrum Disorder (ASD) is rapidly and inexplicably rising with 1 in 36 US children
diagnosed in 2023, yet little is known about its etiology. ASD is debilitating and poses great societal and
economic burdens, thus a critically important public health need is to understand its origins. However, this has
been hindered by the heterogeneous presentation of the core behavioral domains in ASD, which include deficits
in social communication, restricted/repetitive behavior and interests. Genetics account for only 30-40% of ASD
heritability, suggesting that environmental stressors such as immune activation or pollutants, transferred via the
mother may confer risk to offspring. Abnormal fetal brain development is regulated by the placenta and ASD
has been associated with placental epigenetic dysfunction. Identification of placental gene biomarkers that are
causally related to ASD-risk in offspring could help elucidate early pathogenesis and prediction of ASD. Prenatal
exposure to per- and polyfluoroalkyl substances (PFAS) or “Forever Chemicals”, found in ppm levels in drinking
water, is suspected of elevating ASD risk through immune dysfunction. PFAS immunosuppressive effects may
aggravate actions of other environmental stressors such as maternal immune activation (MIA). For example,
viral infection during pregnancy can double the risk of ASD in offspring. Therefore, a critically important, but
unmet need, is to understand how environmental “hits” during development may interact with genetic
predisposition to exacerbate ASD risk using a placental-fetal model. During pregnancy, the common PFAS
species, perfluorooctanesulfonic acid (PFOS) bioaccumulates in placenta and is transferred to fetal brain.
Together, these data suggest that some environmental ASD risk factors could be avoided yet no experimental
studies have investigated the ASD-relevant neurodevelopmental effects of PFOS exposure. Our long-term goal
is to examine gene-environment (GxE) interactions at the placental-fetal interface and their consequences on
fetal neurodevelopment and ASD-relevant behavior using loss- and gain-of function studies. As a first step the
proposed studies will test the effects of developmental exposure to 2 PFAS species, PFOS and PFOA at 2
human-relevant doses (0.1 and 0.3 mg/kg/d) on ASD-like behavior phenotypes and accompanying brain
transcriptomics using mass spectrometry, behavioral methods and transcriptomics. Using proinflammatory
cytokine immunoassays, immune dysfunction profiles will also be examined and integrated with ASD-relevant
phenotypes. Our findings will help identify neuroactive PFAS species at translational doses using maternal
transfer in an environmental toxicant model of autism. Our transcriptomics data will inform about how relevant
gene pathways in early fetal neurodevelopmental influence offspring ASD-like traits. This innovative, self-
contained feasibility study is highly receptive to NIEHS’s areas of interest, “identify and validate biomarkers of
susceptibility to exposures“ and “explore their interrelationships and their relevance to ASD risk and related
phenotypes.”

Public health relevance
Project Summary Autism spectrum disorder (ASD) rates are rapidly rising without any therapeutic solutions available due to the lack of biological markers. A critically important need is to understand how multiple environmental factors such as water-contaminating per- and polyfluoroalkyl substances (PFAS) may act as “hits” to increase risk of ASD. We will identify a human relevant dose of PFOS and PFOA using a mouse model to examine ASD-relevant behavioral phenotypes and ASD-risk genes at the placenta-fetal interface.